University of Michigan Training Program in Genomic Science

Genomics has assumed a central role in the biomedical sciences. The explosive growth of genomic data, the remarkable advances in computing and data science, and the increasingly quantitative nature of biomedical research have resulted in an ever-increasing demand for individuals trained at the interface of genetics and genomics and the mathematical and computational sciences. The NHGRI has convened multiple workshops over the years focused on quantitative training in genome science. Workshop reports have consistently noted a critical need for leaders and innovators to develop the methods and tools needed to analyze the vast amounts of data generated from genomic and other -omics studies and their rapidly emerging technologies. In the most recent NHGRI strategic planning process, advisors strongly advocated expanded commitment to genomic data science training, noting “All major genomics breakthroughs to date have been accompanied by the development of groundbreaking statistical and computational methods. Accordingly, continued innovations … should be prioritized.” The University of Michigan Genome Science Training Program (GSTP) was one of the first NHGRI-funded T32s; in our 29 years, we have trained 151 individuals. While the GSTP continues to evolve to ensure trainees are able to address cutting-edge research questions in genomics, the fundamental premise of the GSTP remains the same: that graduates should have substantial training in the mathematical/ computational and biological sciences and at their interface. This training facilitates communication between disciplines, identification of important problems, and development of the statistical and computational tools to solve those problems. This training prepares future leaders and innovators in statistical and computational genomics, genomic epidemiology, bioinformatics, data science, and molecular genomics. The GSTP is based in four core departments: Biostatistics; Epidemiology; Human Genetics; and Computational Medicine and Bioinformatics, with additional faculty in the seven other participating departments of Anthropology; Biological Chemistry; Ecology and Evolutionary Biology; Environmental Health Sciences; Microbiology and Immunology; Nutritional Sciences; and Statistics. The GSTP has demonstrated a clear commitment to and impressive success in training quantitative genome scientists. We request support for thirteen predoctoral trainees, consistent with the last five years. The University of Michigan demonstrates its own commitment to the GSTP with $3.8 million in support for the next five years. Trainees will be supported for two years (occasionally three) to provide the time needed to embark on the interdisciplinary training we have demonstrated is critical to their success. GSTP alumni will continue to help fill the need for quantitative genome scientists, and in so doing, help the NHGRI achieve its goals of translation of genomic information to improve human health.

Public health relevance
This proposal seeks continued support for the University of Michigan Genome Science Training Program (GSTP). The goal of the GSTP is to train graduate students to be leaders working at the interface of genetics and genomics and the mathematical and computational sciences, a critical area of genome science in which well-trained individuals are in high demand and short supply. The GSTP has a demonstrated record of success having trained >150 scientists and leaders in genome science.